Alteration and Renovation

ABSTRACT/PROJECT SUMMARY – ALTERATION AND RENOVATION
Center of Biomedical Research Excellence (COBRE) in Nutrition and Women’s Health
As part of this the COBRE in Nutrition and Women’s Health, a new and unique Nutrition Analytics Core La-
boratory (NACL) will be created. This facility will operate as the hub for equipment and expertise that serve
various aspects of nutrition- and health-related analyses and approaches. The NACL will be a “one-stop-shop”
for faculty and students who wish to conduct nutrition and health research. The University of Idaho has com-
mitted substantial space for the NACL that will be improved by alterations and renovation. Our goal is to alter
and renovate several adjoining spaces in the University of Idaho’s Food Research Center that will constitute
the “hub” of the NACL. We will accomplish this goal through two aims: 1) Alter or renovate rooms in the Uni-
versity of Idaho’s Food Research Center to house the NACL that will be used by research project leaders
(RPLs), Pilot Project awardees, Technology Access Grant (TAG) recipients, and new and existing faculty and
students conducting research related to nutrition and women’s health, and 2) Delineate and justify all major
fixed equipment items requested for the renovated area. The NACL is innovative as it will eventually provide a
comprehensive facility that addresses nearly all aspects of data collection and analyses pertinent to nutrition
research. It spans the needs of scientists conducting basic biological experiments to those focused on social or
behavioral aspects of nutrition to those developing novel computational approaches to understand impacts of
nutrition on women’s health. Our approach is significant and impactful because it allows researchers (regard-
less of their fundamental primary research focus) unparalleled ability to study the broad range of nutrients,
physiological conditions, and health outcomes that encompass nutrition and women’s health.